Polarity dysregulation in Alzheimer’s disease

Project Summary
The vast majority of Alzheimer’s disease (AD) is sporadic, with aging being the biggest risk factor. Yet age-
related changes within neurons that can facilitate AD pathogenesis remain elusive. Intriguingly, there is an
intricate link between aging and cell polarity. Dysregulation of polarity is observed in many cellular contexts
during aging, such as increased permeability of epithelial barriers, defective asymmetric division of stem cells
and increased frequency of cancer. Similarly, dysregulation of cellular polarity and compartmentalization
are observed in AD neurons, with redistribution of axonal tau to the somatodendritic compartment and
progressive loss of synaptic contacts. However, the mechanisms underlying this polarity dysregulation remains
unclear. Remarkably, several recent genetic studies have identified PARD3, encoding the polarity protein
partitioning defective 3 (Par3), as a potential novel risk gene for AD and related tauopathies. In addition, our
recent work revealed Par3 shows significantly reduced expression by middle-age, and a further loss of Par3 is
observed in human AD brains. Loss of Par3 increases compartmentalized APP/BACE1 convergence of
amyloid precursor protein (APP) with its β-secretase BACE1, leading to intracellular β-amyloid (Aβ)
accumulation. Moreover, we found forebrain conditional knockout (cKO) of Par3 leads to age-dependent tau
pathology and cognitive decline, and loss of Par3 results in autophagosome accumulation, all prominent
features of AD brains. Finally, phosphoproteomic profiling in Par3 cKO hippocampus reveals changes in
microtubule binding proteins that are important for neuronal polarity. These exciting data have led to our
central hypothesis that polarity dysregulation in aging brains leads to microtubule-based membrane
transport defects that contribute to cognitive impairments in AD. Specifically, we hypothesize that loss of
Par3 disrupts compartmentalized microtubule dynamics, leading to defects in polarized endolysosomal
trafficking and autophagic flux in AD neurons. Aim 1 will test the hypothesis that loss of Par3 in AD disrupts
polarized endolysosomal trafficking through differential regulation of dendritic and axonal microtubules. Aim 2
will test the hypothesis that loss of Par3 causes defects in autophagy and restoration of Par3 ameliorates AD
pathologies. Our studies will utilize advanced molecular imaging techniques, including tauSTED super-
resolution imaging, FRET, FRAP, and optogenetic manipulations of cellular and molecular activities. We
combine different molecular imaging approaches with biochemical and phosphoproteomic analyses, as well as
behavioral analysis in novel Par3 conditional knockout and Par3 conditional knockin mouse models. Taken
together, our proposed studies will establish the molecular mechanisms by which loss of Par3 in the aging
brain contributes to cognitive deficits in AD progression and whether restoring Par3 expression can ameliorate
AD pathologies. The results will shed light on the mechanism of sporadic AD in which aging is the major risk
factor and polarity dysregulation may be a common feature.

Public health relevance
Project Narrative Several recent genetic studies have implicated a protein called Par3 in Alzheimer’s disease (AD) and related tauopathies. We recently found in aging and AD brains, there is a loss of Par3, and forebrain loss of Par3 causes age-dependent cellular and cognitive defects similar to AD. Our proposed studies will further elucidate the signaling mechanisms of Par3 relevant to AD progression, which will shed light on the pathogenic mechanisms of AD and can potentially lead to novel therapeutic strategies.